NON-CLINICAL STUDIES IN SUPPORT OF IND/NDA/BLA SUBMISSIONS

This contract provides support services to develop a product against injuries resulting from radiation exposure to include development of and testing of medical countermeasures in animal models of radiation injury, as well as provision of samples for biodosimetry studies.